Combining neural oscillations, physiology and privacy-preserving LiDAR/millimeter wave sensing technology to track attention states in natural contexts

Project Summary
Impairments of attention are common across neurodevelopmental disorders (e.g., ADHD), and contribute to
negative life outcomes such as in academic achievement. Critically, leading treatment strategies are ineffective
at improving educational outcomes. Lacking is assessment of attention deficits in real-life contexts, where
visuospatial attention circuitry is influenced by interactions with regulatory systems including arousal and
motivation. As such, tracking of neuro-behavioral attention states in natural environments has been
increasingly recognized as crucial to: (i) understanding the interaction between neural circuitry of attention and
regulatory influences, and (ii) identifying pathways to improving behavioral outcomes. Several technical
challenges in this effort exist, however, and include quantification and synchronization of objective measures
of such interacting systems with neural indicators of attention, portability of such multi-modal assessment
systems, and increasingly, protection of privacy, with video recordings a gold standard in the field. The
objective of this R61/33 proposal is to address these challenges.
We will (Aim 1) develop an integrated, portable sensor suite for concurrent recording of neural activity,
physiological arousal, motor signals, and physical interactions in social environments. We will integrate our
previously developed tracking of neural oscillatory features of visual attention with additional sensors (heart
rate, motor, and novel LiDAR/millimeter wave sensing) to extract physiological and movement-derived
features of arousal and motivation. Project milestones quantify our aims to (i) optimize synchronization &
portability, while (ii) introducing privacy-preservation technology to eliminate reliance on video recordings, and
(iii) achieve above-chance classification of system states, and overall attention state as expressed in behavior.
Next, we will deploy this technology to explain and predict neuro-behavioral attention states during mock-
classroom and real-classroom learning activities, while manipulating contextual variables such as degree of
attention support (group vs individual work), motivation (rewarded activities) and arousal (testing context). We
will test the hypotheses (Aim 2) that (i) a multi-dimensional profile of attention states will improve prediction of
neural activity and behavioral attention states and delineate how visual attention circuitry and regulatory
influences interact in natural contexts, while also (ii) accounting for individual variability in inattention by
differentiating between causal pathways to inattention, and (iii) identifying individual learning contexts that
optimize an individual’s attention.
The result of the project will be a scalable, integrated, portable technology designed to improve the accuracy
of determining sources of inattention on individual basis, thus allowing for more targeted treatments.

Public health relevance
Project Narrative This project aims to develop a portable integrated sensor suite for multidimensional tracking of neuro-behavioral attention states in natural contexts. We will develop novel technology to address quantification, synchronization and privacy concerns of measuring brain, physiological and movement signals in natural contexts, and then deploy this technology in the classroom setting to identify predictors of neuro-behavioral attention states in children during learning. The results will be a scalable technology to improve accuracy of determining sources of inattention in a given individual, allowing for more targeted treatments, especially in neurodevelopmental disorders (ADHD, autism, learning disorders) and vulnerable populations. .